Synthesis of cannabidiol dimers as potential agents to treat neurological disorders

The COVID pandemic has worsened stress, anxiety, and depression in the US population. Current FDA
approved therapeutics for these ailments are only effective in subpopulations, and it is very common for
patients to have to attempt multiple regimens to find one that works. Not surprisingly, patients continue
seeking alternative remedies for self-treatment, e.g., cannabis. However, regardless of the legalization of
cannabis in many states and its widespread usage for these purposes, cannabis is a diverse mixture of
hundreds of compounds that widely vary in amount depending on the cannabis source. One active
component of cannabis, cannabidiol (CBD), has been individually studied for its medicinal activity.
Epidiolex®, a highly purified form of CBD, is FDA approved to treat rare forms of epilepsy. The issue is that
CBD – in its natural form – is a non-specific (poly-pharmacological) agent. CBD weakly activates several
receptors of the following classes: cannabinoid, opioid, serotonin (5-HT1A, 5-HT2A), orphan-GPR55,
adenosine, and TRP receptors, among others. It remains unclear which receptor(s) and signaling pathway(s)
are crucial for the positive benefits of CBD. Our long-term goal is to identify and expand novel therapeutics
with defined, specific mechanisms of action for neurological/mental disorders. In this light, the overall
objective in this application is to create novel CBD dimers that are proposed to be specific to cannabinoid
or serotonin receptors. We will assess the hypothesis that CBD homo/heterodimers will enhance the
selective binding to cannabinoid and serotonin receptors through bivalent or bitopic binding on dimerreceptors
or a single receptor on two sites, respectively. Upon generation of our CBD homo/heterodimer
library, we will evaluate their selectivity for the above receptors, and we will also evaluate dimers in a
psychoactive receptor panel (NIMH-PDSP). This will position us to build key preliminary data for a competitive
NIH application. Development of these novel dimers as chemical biology probes will elucidate the interactions
of CBD with serotonin and cannabinoid receptors and the structural details behind these activities. Ultimately,
these CBD semisynthetic derivatives have the potential to yield favorable therapeutic indices for the treatment
of stress, anxiety, and depression. Results consistent with our hypothesis will have wide-ranging public health
implications because of societal interest in CBD despite its poorly understood activities and because of the
urgent need for safe, effective therapies. Importantly, if successful, the long-term goal is to move promising
compounds into advanced preclinical testing.